Effects of aortic compliance and Windkessel reduction on cardiac and aortic pathophysiology

PROJECT SUMMARY
Aortic elasticity creates a Windkessel effect. That is, aortas distend following ejection of blood from the left
ventricle (LV) during systole, and then recoil after aortic valve closure. This feature of ventricular-arterial
coupling blunts peak blood pressure and flow waves providing a cushioning effect that protects the heart from
pressure injury. In addition, the Windkessel effect helps move blood distally through the coronary arteries and
periphery during cardiac relaxation. Aortic stent-grafts are made of stiff materials that artificially stiffen the aorta
and diminish the Windkessel effect. This may overwork the heart, eventually leading to pathological changes.
While stiff stent-grafts are generally thought to work well in the aorta, the subtle long-term effects associated
with stent-grafting may not be reported in the stent-graft literature that focuses primarily on mortality and local
complications requiring re-intervention. Recent evidence from our team demonstrates that implantation of stiff
thoracic aortic stent-grafts in young trauma patients is associated with significantly increased LV mass and wall
thickness, and in pigs results in aortic stiffening and early LV fibrosis. Similar outcomes were recently reported
in elderly patients with thoracic and abdominal aortic stent-grafts. In order to mitigate these effects and
preserve aortic compliance, our team has developed a new elastomeric nanofibrillar aortic stent-graft that
possesses aorta-like mechanical properties and microstructure, and is able to preserve aortic elasticity and the
Windkessel effect, and maintain normal pressure waveforms as opposed to stiff conventional stent-grafts in
vitro. Furthermore, in vivo our nanofibrillar material maintains its compliance, undergoes rapid
endothelialization, and gets quickly incorporated into the arterial wall. We propose to test the hypothesis that
preservation of aortic compliance with a new-generation compliant stent-graft results in normal
hemodynamics and prevents cardiac and aortic pathologies. This hypothesis will be tested through 3
Specific Aims. In Aim 1 we will manufacture nanofibrillar elastomeric stent-grafts with tunable compliance. In
Aim 2 we will quantify the effect of stent-graft compliance on Windkessel function in human and porcine aortas
using an ex vivo flow model. Finally, in Aim 3 we will assess the in vivo effects of stent-graft compliance on
hemodynamics and cardiac and aortic pathologies in a swine model. This will be done by comparing the
effects of aortic compliance and Windkessel reduction on the heart and the aorta when using commercial
stent-grafts versus devices made using stiff and compliant nanofibrillar materials. This project will quantify the
effects of stiff stent-grafts on aortic compliance and cardiac pathophysiology, and will propose a new-
generation stent-graft that protects the aorta and the heart from pathologic remodeling. While compliance is
highest in young aortas, older patients with weaker hearts may be most sensitive to its alteration. Considering
the ubiquitous use of stiff stent-grafts in patients of all ages, the clinical importance of better minimally-invasive
aortic devices is difficult to overestimate.

Public health relevance
PROJECT NARRATIVE Stent-grafts are devices frequently used to repair diseased or injured aortas. Though aortas are stretchy, these devices are stiff and may impose abnormal stress on the heart and the aorta. We will study the effects of stiff stent-grafts in pig and human aortas, and develop a new compliant device that prevents damage to the heart.